Mitigation of lymphatic injury by retinoic acid therapyin a large animal model

Lymphedema is an incurable condition characterized by lymphatic obstruction, tissue swelling, immune dysfunction, and fibrosis after lymphatic injury. Lymphedema affects 5 million Americans and is associated with poor quality of life due to extremity disability, disfigurement, and risk for recurrent limb-threatening infection. In the US, lymphedema is most commonly a consequence of lymph node dissection for the treatment of malignancies such as breast or pelvic tumors. Once established, this disease is progressive and difficult to treat. We have previously demonstrated that administration of 9-cis retinoic acid (9-cis RA) at the time of lymphatic injury can stimulate lymphangiogenesis and mitigate disease progression in mice. A critical step in translating these findings to the clinical setting involves demonstrating efficacy in a second, non-rodent, large animal model. To address this, we have chosen swine due to the fact that it has soft tissue anatomy and physiology that is more similar to human than rodent models. While the central goal of this proposal will be to determine if 9-cis RA can prevent postsurgical lymphedema in swine, the two specific aims of this proposal include Aim 1: To determine the effect of 9-cis RA on limb volume, MRI characteristics, and lymphatic transport after critical lymphatic injury in swine; and Aim 2: To assess the effect of 9-cis RA on the histopathological and molecular changes in tissues at the site of critical lymphatic injury in swine. Completion of this proposal will yield highly relevant and translatable findings that will facilitate development of a 9-cis RA based therapeutic approach to prevention and management of secondary lymphedema in humans.

Public health relevance
Lymphedema is an incurable condition that affects over 5 million individuals in the US and is characterized by tissue swelling after lymphatic node injury or resection. There is no pharmacologic therapy that is currently approved to prevent post-surgical lymphedema. Our laboratory has shown that 9-cis retinoic acid therapy mitigates lymphedema after surgical injury by promoting lymphangiogenesis in murine hind limb and tail models. To support further clinical translation of this novel therapy to human trials, this proposal seeks to further investigate the effects of 9-cis retinoic acid in a second, non-rodent, swine large animal model.